Environmental Health Sciences Research Center

The Environmental Health Sciences Research Center (EHSRC) will advance and translate research that addresses environmental health problems across the urban-rural continuum. Rural America faces unique environmental challenges from exposure to farm chemicals, air and water pollution from livestock and agricultural production, rural manufacturing, and the green energy economy. The EHSRC is at the forefront of research in rural environmental health, determining the role of innate immunity and the inflammasome in lung disease; the role of the microbiome in health and disease; state-of-the-art biomedical imaging with advanced computational modeling to assess the effect of inhaled toxicants; and applications for distributed sensor networks and data analytics for exposure monitoring. The Center applies innovations, for example, in advanced -omics technologies, population-based animal models, and advanced lung imaging, to advance this research. The EHSRC vision is to be the primary environmental health sciences (EHS) resource for improving the health of rural residents in the Midwest by stimulating and translating innovative environmental health sciences research. This is accomplished by enhancing the careers of Center investigators and through our translational research vision to translate new insights from rural exposures; population health; individual susceptibilities; and pathways of toxicity, disease, and repair to enhance environmental health literacy, public health practice, regulatory policy, new clinical treatments, and precision environmental health. Center goals are to: 1) enhance the effectiveness of environmental health sciences research and extend the focus of research in five Thematic Areas, including Inflammation and Innate Immunity, Nanoscience, Population Health, Systemic and Redox Toxicology, and Water Quality; 2) recruit, mentor, and nurture a broad group of investigators interested in the environmental health sciences, with an emphasis on recruiting and grooming future leaders in the field; and 3) engage with communities and other audiences to translate research knowledge toward improving the health and environment of rural people in the Midwest and the nation. The interdisciplinary research of the EHSRC is organized around its Thematic Areas and supported by three facilities, the Integrated Health Sciences Facility Core (IHSFC), Exposure Science Facility (ESF), and Pulmonary Toxicology Facility (PTF). These facilities provide cost-effective and cutting-edge services and state-of-the-art equipment. An Administrative Core provides transformative leadership, leverages institutional support, and manages highly effective Pilot Grant and Career Enhancement Programs that provide resources and mentoring to advance the careers of promising early-stage investigators. The Community Engagement Core engages the Center’s audiences to ensure the relevance of EHSRC research and, in collaboration with the IHSFC, translates research to environmental public health

Public health relevance
PROJECT NARRATIVE - OVERALL The Environmental Health Sciences Research Center (EHSRC) is the primary environmental health sciences resource for improving the health of rural residents by stimulating and translating innovative environmental health sciences research. This is accomplished by supporting original research addressing rural exposures; population health; susceptibilities; and pathways of toxicity, disease, and repair to enhance environmental health literacy, public health practice, regulatory policy, new clinical treatments, and precision environmental health. The EHSRC supports five Thematic Areas which serve as intellectual hubs, three research facility cores, a Pilot Grant Program, a Career Enhancement Program and a Community Engagement Core that collectively develop fundamental knowledge about living systems to enhance health and reduce the burden of human disease, with an emphasis on rural populations.